Cognitively-enhanced tDCS of the dorsolateral prefrontal cortex to reduce craving in cocaine addiction

Over the past decade, the US has been affected by a re-emerging stimulant use public health crisis and alarming
increases in crack/cocaine-related overdose deaths. In contrast to other types of addiction, there are no FDA
approved treatments for crack/cocaine use disorder (CUD). Developing and testing evidence-based treatment
options for this population, and exploring the underlying neural substrates, are therefore urgently needed. Core
symptoms of addiction are craving and enhanced reactivity to drug cues, attributed to impairments in prefrontal
cortical-mediated functions that include reduced inhibitory control. Using a battery-powered portable device that
can be used safely, remotely and repetitively, we have shown in a Phase-1 pilot trial that 15 sessions of real (vs.
sham) transcranial direct current stimulation (tDCS) over the dorsolateral prefrontal cortex (dlPFC) reduced
craving in individuals with CUD. Combining tDCS with cognitive/emotional training is optimal, as supported by
human (and mechanistic) studies. Therefore, here tDCS will be administered during a dlPFC-dependent learning
strategy, namely cognitive reappraisal (CR) of drug cues, shown to reduce motivated processing of and
spontaneous attention bias to these salient cues in CUD, improving clinical outcomes in drug addiction. With
four groups (total N=120), comprised of real- vs. sham dlPFC tDCS crossed over with CR vs. no CR, we will
perform a double-blind randomized trial in the natural setting where individuals with CUD receive inpatient
treatment. We will also test the feasibility of training in self-administration (for the ultimate design of remotely
delivered trials). Our working hypothesis is that synergistically enhancing dlPFC function by combining tDCS
with CR, a cognitive training, will decrease craving and cue-reactivity in CUD. Specifically, we hypothesize a
real-tDCS vs. sham beneficial effect. In exploratory analyses, we will test whether this effect is modulated by CR
(vs. no CR). Our main outcome measure, craving (and drug use measures), will be assessed at all study sessions
and at a one month follow-up. Using a reliable and valid inhibitory control fMRI task before and after the tDCS
trial (in all four groups) will allow ascertaining whether dlPFC recovery (post>pre tDCS) underlies the expected
craving reductions (expected to be strongest during real-tDCS+CR) and identify biomarkers predictive of
outcomes. Thus, in this project we will explore an entirely novel learning paradigm approach, using electrically
enhanced neurocognitive training to modulate the neural networks underlying inhibitory control with the
therapeutic goal of reducing craving (and hence drug use and relapse) in treatment-seeking inpatients with CUD.
In addition to testing this novel intervention, the identification at baseline of predictive MRI-based measures could
later be used for the design of timely prevention efforts. Establishing feasibility of self-administration and
harnessing ecological validity by venturing to the clinic to enhance recovery in inpatients with CUD at the
time/place it is most needed, we aim to empower patients with drug addiction with real-time lifesaving tools.

Public health relevance
We will test whether cognitively enhanced transcranial direct current stimulation (tDCS) of the dorsolateral prefrontal cortex can reduce craving in inpatients with cocaine use disorder. Neuroimaging before and after stimulation will establish the neural correlates of recovery and allow predictions of outcomes, which will be assessed throughout the study and one month after its completion. Results could pave the way towards development of a new self-administered intervention to reduce craving when it is needed the most, enhancing recovery real-time and in the natural environment in people with cocaine addiction as generalizable to other drugs of abuse and other disorders of self-control.